Interaction between dietary taurine and microbiota sulfur metabolism in the development of colorectal cancer

Colorectal cancer (CRC) incidence has been steadily increasing in subjects younger than 50 years old. A
relatively recent body of literature suggests CRC could be the result of interaction between dietary components
and specific microorganisms. Identification of carcinogenic diet-bacteria interplay would deliver potentially new
insight for CRC prevention and treatment. Previous studies revealed that diet rich in microbially accessible sulfur
is associated with relative enrichment of Bilophila wadsworthia in the gut and higher risks of CRC including early
onset CRC. Energy drinks, the second most popular dietary supplement of teenagers and young adults,
commonly contain high amounts of the sulfur amino acid taurine. Taurine can be metabolized by Bilophila
wadsworthia to produce H2S, which exhibits DNA-damaging activity at physiological levels. Our preliminary data
show that while taurine supplementation protects against colitis and colonic cancer development in the absence
of B. wadsworthia, B. wadsworthia colonization together with taurine supplementation promotes development of
neoplastic lesions in DSS/Apcmin/+ mice. Taurine and B. wadsworthia, alone or in combination, significantly alter
the microbiota composition along CRC development. Importantly, taurine supplementation favors B.
wadsworthia gut colonization in mice, suggesting active taurine-B. wadsworthia interplay. In this application, we
propose to test the hypothesis that B. wadsworthia-mediated taurine-H2S biotransformation determines the
impact of dietary taurine on individual’s gut homeostasis, inflammation and carcinogenesis. We plan to test this
hypothesis with the following specific aims:
Aim 1. Determine the interaction between dietary taurine and B. wadsworthia in intestinal inflammation
and tumorigenesis. The hypothesis is that taurine favors production of disease-promoting H2S by sulfur-
metabolizing bacteria such as B. wadsworthia. We will define the impact of taurine and energy drink
supplementation on mouse colonic inflammation and tumorigenesis in relation to B. wadsworthia colonization
status and metabolic activity. Aim 2. Determine the mechanism by which H2S exerts neoplastic effect. We
will determine host genes regulating responses to H2S genotoxicity using whole genome CRISPR/Cas9 genetic
screen, and elucidate the in vitro and in vivo mutational signatures induced by H2S and B. wadsworthia taurine
metabolism respectively. Aim 3. Evaluate the impact of energy drink consumption on microbiota function
from a healthy young adult cohort. We will leverage an ongoing interventional trial where longitudinal stool
samples are collected from healthy young adults before and after energy drink consumption to determine
microbiota functional capacity changes. We will perform fecal microbiota transplantation in gnotobiotic
DSS/Apcmin/+ mice to compare carcinogenic activities of feces collected pre- and post-energy drink consumption.
This project will provide key knowledge to prevent intestinal inflammation and carcinogenesis through modulation
of taurine intake or bacterial metabolic activity.

Public health relevance
Colorectal cancer (CRC) rates have been steadily increasing in subjects younger than 50 years old, suggesting that environmental factors may be responsible for this rise. The project will establish the contribution of sulfur- metabolizing bacteria and dietary taurine in CRC development. This knowledge will serve to develop novel strategies to prevent CRC.